Deployable Ultrasound Applicators for MRI Guided Thermal Therapy of Pancreatic Cancer

PROJECT ABSTRACT:
The overall objectives of this research plan are to produce low profile endoluminal ultrasound applicators
with deployable lens/reflector systems, in conjunction with real-time MRI guidance and MR temperature
imaging (MRTI), to allow for localization and precise delivery of thermal ablation or hyperthermia in the
treatment of pancreatic cancer. Pancreatic cancer is the fourth most deadly cancer in the USA, with only
~20% of patients eligible for surgery. Radiation therapy and chemotherapy remain the standard of care,
but have modest improvements to survival and significant morbidity. Recent clinical studies indicate
thermal therapies may provide palliation, reduce tumor burden, and increase survival. Extracorporeal
High-Intensity Focused Ultrasound (HIFU) systems can deliver precision pancreatic tumor ablation,
although there are limitations with respect to tumor size, accessible locations, damage to adjacent tissues,
and an inability to deliver deep volumetric hyperthermia into the abdomen. Recent laboratory and clinical
studies support a possible role for hyperthermia therapy as an adjunct to radiation, chemotherapy, targeted
drug release, and immunotherapies. Our expertise and experience developing ultrasonic devices and
techniques for MR guided thermal therapy, along with preliminary data, indicate that ultrasound applicators
with deployable assemblies, positioned within the stomach or duodenum under MR guidance, are feasible
and have potential to provide the means to deliver precision ablation and hyperthermia for the treatment of
pancreatic cancer. These innovative reflector/lens balloon systems allow the ultrasound applicators to be
positioned with MR guidance in a body lumen under low profile, and then deployed and expanded when in
position to produce a larger acoustic aperture for deeper focusing or volumetric hyperthermia, expanding
the range and utility of this approach. The goals of this project are: (1) to apply theoretical and advanced
experimental design to develop forward-fire and side-fire ultrasound deployable reflector/lens assemblies
suitable for endoluminal insertion into the stomach or duodenum, and optimized for penetration and spatial
control required for localization of therapy; (2) to further develop acoustic and thermal computer
simulations, apply 3D patient specific simulations to assess heating performance, design delivery
strategies, and develop a treatment planning framework; (3) to develop MRI guidance and MRTI for
accurate delivery and monitoring, using rapid acquisition with hybrid referenceless and multibaseline MR
thermometry to accommodate physiologic organ motion; and (4) to perform in vivo studies of the
deployable ultrasound applicators and MR guidance platform, and to use MRTI, contrast enhanced MRI,
and histology to assess the ability and accuracy to target ablation and hyperthermia of pancreatic tissue
while sparing adjacent tissues. Completion of this proposed study has potential to lead to a novel and
accurate minimally-invasive method for treating pancreatic cancer with thermal therapy, with discretion to
avoid damage to non-target tissues, and can be used alone or as a powerful adjunct to other therapies.

Public health relevance
PROJECT NARRATIVE: The goals of this R01 application are to: 1) apply theoretical and experimental design to develop deployable ultrasound applicators for endoluminal delivery of thermal therapy to the pancreas; 2) develop advanced MRI guidance and temperature monitoring methods specific to this application; and 3) through animal studies establish feasibility, performance, and limitations toward clinical implementation. This research will have substantial impact by providing a precise and minimally-invasive method for delivering thermal therapy for the management of pancreatic cancer in patients where surgery is not an option and survival is limited. The proposed image-guided therapeutic approach may also have future applications for treatment of other pelvic, thoracic, and abdominal cancers.